Neural Mechanisms of Energy Expenditure-Induced Compensatory Food Intake

Project Summary
Obesity is a major public health problem. Modulating energy expenditure through behavioral or
pharmacological intervention is a key strategy to alter energy balance and battle obesity and metabolic
diseases. Targeting molecular pathways underlying the cold-induced non-shivering thermogenesis has been
an important and promising strategy to elevate energy expenditure in animals and humans. However, it is well-
known that mammals compensatorily increase food intake due to higher expenditure, such as in the cold.
While it is generally agreed that the brain centrally controls this feedback, the neural mechanism underlying
this coupling is largely unknown. Here, we propose to systematically investigate the behavioral, metabolic, and
circuit basis of cold-induced feeding. By combining calorimetry and behavioral modeling, our preliminary study
demonstrated that cold-induced increase of food intake involves dynamic bi-directional behavioral switches
and is mediated by non-canonical feeding circuits. Using whole-brain clearing, lightsheet imaging, and c-fos
activity screening, we identified a group of nuclei at the ventral midline thalamus (vMT) associated with cold-
induced feeding. The central hypothesis is that the vMT nuclei are activated by the elevated energy
expenditure and recruit downstream targets to mediate cold-induced feeding. The first aim is to use in vivo
calcium imaging to measure the endogenous activity of vMT in relationship to cold and feeding behaviors. The
second aim is to use optogenetic and chemogenetic approaches to determine the causal significance of vMT
neural activity in driving cold-induced feeding. The third aim combines anatomical mapping and functional
manipulation to study how vMT integrates into the well-established feeding circuits in hypothalamic and limbic
systems. The completion of these studies will provide a new understanding of the coupling between energy
expenditure and intake in the brain, bringing many opportunities to leverage these mechanisms to maximize
and maintain the metabolic benefits from targeting energy expenditure.

Public health relevance
Project Narrative Increasing energy expenditure is a promising strategy for treating obesity and metabolic diseases; however, a compensatory increase in food intake could dampen its benefits. We will use cold and thermogenesis-induced feeding in rodents as a model to investigate the neural mechanisms underlying the compensatory energy intake. This project aims to provide insight into how to effectively modulate energy homeostasis at the whole organismal level to battle metabolic diseases.